CRCNS US-German Research Proposal: Efficient representations of social knowledge structures for learning from a computational, neural and psychiatric perspective (RepSocKnow)

PROJECT DESCRIPTION
US-German Research Proposal for Collaboration in Computational Neuroscience:
Efficient representations of social knowledge structures for learning from a computational, neural
and psychiatric perspective (RepSocKnow)
US-side PI: Prof. Gabriela Rosenblau, Ph.D., Assistant Professor, Department of Psychology, The George
Washington University, 2115 G Street NW, Washington, DC 20052
German-side PI: Prof. Christoph W. Korn, Ph.D., Assistant Professor & PI Emmy-Noether Group, Section
Social Neuroscience, Department of General Psychiatry, University of Heidelberg, Vossstraße 4, 69115
Heidelberg, Germany
Consultant 1: Prof. Daniela Schiller, Ph.D., Associate Professor, Department of Psychiatry, Department
of Neuroscience, and Friedman Brain Institute, Icahn School of Medicine at Mount Sinai, 1470 Madison
Ave, New York 10029, NY
Consultant 2: Jan Gläscher, Ph.D., PI Bernstein Research Group, Institute for Systems Neuroscience,
University Medical Center Hamburg-Eppendorf, Martinistrasse 52, 20246 Hamburg, Germany
1. Aims and hypotheses
This is a resubmission of our last year's CRCNS proposal, which received good and very good scores from
reviewers. Reviewers were excited about the general neuro-computational approach that builds on the
complementary skills of the PIs. In this revision, we address the reviewers' requests for clearer descriptions
of the planed experiments and analyses. Importantly, our new proposal has direct relevance for clinical
practice. By leveraging ideas from computational psychiatry [1–4] and from the Research Domain Criteria
(RDoC; e.g., [5, 6]), we aim to apply our neuro-computational approach to improve the understanding of
core social deficits shared by many pervasive neuro-psychiatric disorders. The general goal of this proposal
is to establish comprehensive—and clinically relevant—neuro-computational models of aberrant learning
in social contexts via behavioral and functional magnetic resonance imaging (fMRI) experiments.
Learning about others is crucial for successful social interactions [7]. Social interactions strongly
predict wellbeing [8]. Different types of impairments in social functioning accompany a variety of clinical
conditions and constitute core symptoms of Autism Spectrum Disorders (ASD) [9–11] and Personality
Disorders with a Borderline pattern qualifier (BPD) [12–16]. We harness our neuro-computational approach
to investigate how social knowledge structures shape—and in turn are shaped by—learning about others.
The mechanisms underlying knowledge representations and learning that we propose in our computational
modeling approach are not “social” per se and we deem it a strength that they can be applied to learning
across various (non-)social domains.
Here, we focus on social learning to specify commonalities and differences between healthy
individuals and individuals with marked social deficits associated with ASD or BPD. While these two
clinical groups probably both employ overly rigid social knowledge structures, they exhibit different types
of malfunctioning: ASD are characterized by under-mentalizing, i.e., insufficient inferences about mental
states of others—possibly due to poor or unspecific social knowledge[17–19]. In contrast, BPD show over-
mentalizing and overly negative interpretations of others' personality or intentions[12, 13]. Our novel
neuro-computational framework can improve the understanding social malfunctioning along dimensional
and categorical psychiatric criteria of ASD and BPD.
We aim to test and refine computational models that formalize adequate strategies for acquiring
and employing social knowledge structures during learning. Our models offer normative perspectives on
social learning by specifying how ideal agents could learn in our controlled but ecologically valid tasks.
Thereby, we can quantify how much humans—particularly clinical populations characterized by pervasive
social deficits—deviate from computationally specified “optimal” benchmark strategies. In conjunction,
this project aims to reveal the neural computations underlying the representation of social knowledge
structures and their flexible deployment during learning. The project addresses three specific aims: